Neuroprotection by a Secreted Component of the Cellular Stress Response

PROJECT SUMMARY
We found that neurons secrete a soluble protein that protects neurons under cell stress conditions in a
paracrine manner. Remarkably, this protein is derived from the C-terminus of the endoplasmic reticulum (ER)
membrane bound transcription factor CREB3L2. Proteolytic cleavage liberates the N-terminal transcription
factor and leads to the secretion of the ER luminal domain into the extracellular space. Our preliminary data
indicate that the production and secretion of this C-terminal domain is triggered by cell stress and that it acts
by increasing mitochondrial function via sonic hedgehog (Shh) signaling. In this project we are testing the
general hypothesis that CREB3L2-C is a paracrine component of the adaptive neuronal stress response.
We will culture primary rat cortical neurons and expose them to various cell stress triggers, including oxidative
stress, ER stress, proteasome inhibition, and glucose-deprivation. We will determine whether the activation of
the integrated stress response pathway is necessary and sufficient to upregulate the synthesis and cleavage
of CREB3L2. We will investigate how the luminal C-terminal domain of CREB3L2 is secreted from cells and
whether its secretory pathway is linked to cell stress. To investigate how the secreted C-terminal domain of
CREB3L2 affects neurons, we will purify it and apply it to primary cortical neurons. We will focus on its
proposed role in strengthening Shh signaling and determine whether it forms complexes with Shh and its
receptor Patched-1 on neurons. We will determine whether application of the secreted, C-terminal domain of
CREB3L2 is sufficient to increase Shh signaling and whether enhanced Shh signaling is necessary for its
effects on cell survival and mitochondrial function. To assess the effect of the secreted C-terminal domain of
CREB3L2 on mitochondria, we will employ a variety of tests to quantify changes to mitochondrial mass,
abundance of mitochondrial proteins, and mitochondrial function in neurons under normal conditions and
upon induction of oxidative stress, ER stress, proteasome inhibition, and glucose-deprivation. The cleavage
of CREB3L2 activates necessarily two distinct signaling molecules, the intracellular transcription factor and
the secreted C-terminus. We will use chromatin immunoprecipitation with sequencing in combination with
RNA sequencing to determine the transcriptional targets of CREB3L2 in neurons under baseline and induced
stress conditions, to determine whether both signaling molecule act cooperatively in the adaptive cell stress
response. Lastly, we will use a previously generated conditional CREB3L2 knockout mouse to study the
relative roles of the cell autonomous (i.e. the transcription factor) and the non-cell autonomous arm of
CREB3L2 signaling in neuronal stress response in vitro and in vivo. Together, the results from this project will
uncover a novel intercellular signaling pathway that is activated in response to cell stress in neurons and
confers enhanced resilience and mitochondrial function to receiving neurons.

Public health relevance
PROJECT NARRATIVE The integrative stress response is an evolutionary conserved pathway to allows cells to react to various stress stimuli to restore cellular homeostasis. We found that the activation of this process in neurons leads to the secretion of a protein fragment that enhances the resilience of surrounding cells to cell stress. We propose to study how this signaling molecule is generated and secreted from neurons in response to stress, how it affects recipient neurons, and how its activity is coordinated with transcriptional programs to facilitate cell survival.